Single cell heterogeneity of influenza A virus genetic diversity and host adaptation using drop-based microfluidics

Project Summary
New pandemic influenza A virus (IAV) strains can arise when mutations enable host adaptation. Mutations that
overcome host range restrictions are important in viral emergence and zoonotic infections. Zoonotic spillover
into humans with avian IAV subtypes, such as H5N1 and H7N9, have mortality rates as high as 60%. While
significant progress has identified many mutations that allow IAV to adapt to new host species, we have an
incomplete understanding of the depth of viral mutations generated during viral replication. Defining the
heterogeneity of viral mutations will shed light on the viral genetic diversity that enables zoonotic spillover.
Critically, IAV infection in humans occurs in heterologous cell populations in the respiratory tract that correlate
differently with the likelihood of virus transmission. Single cell analysis of these different cell types with both
human and avian IAV strains will allow us to explore how virus strain and cell type influences viral diversity.
Drop-based microfluidics is a method in which the host cell and virus are compartmentalized within picoliter-
sized drops, creating millions of micro-environments, allowing for high-throughput analysis. Drop-based
microfluidics therefore provides an ideal platform for the study of viral genetic diversity from fast evolving RNA
viruses in the laboratory. Our long-term objective is to understand the evolution of IAV that leads to host
adaptation, virulence, transmission, and ultimately zoonotic spread. To begin to address this long-term
objective we will evaluate single cell IAV genomic heterogeneity by 1.) quantifying the genetic diversity arising
from avian and seasonal human IAV infections of individual human primary cells and 2.) performing
evolutionary studies by serial passaging IAV viruses at a single cell level. These two independent, but
complementary aims are directed at understanding: (Aim 1) how specific cell types impact viral genetic
diversity and zoonotic risk, and (Aim 2) how viral diversity evolves when system and population level
bottlenecks are altered. The proposed research will broadly impact the field of single cell virology by
characterizing the role that viral diversity plays in virus propagation, transmission, and evolution. These studies
will yield fundamental mechanistic insights into virus-host cell dynamics, which may aid in developing
efficacious vaccines and therapeutics that can target rapidly evolving IAV and other RNA viruses.

Public health relevance
NARRATIVE Avian influenza A virus (IAV) infections in humans have high rates of morbidity and mortality rates but remain infrequent because host restrictions limit efficient viral replication and human to human transmission. However, rapid accumulation of mutations within the IAV genome can lead to extensive viral genetic diversity, thus increasing host adaptation, fitness, and transmissibility. We will quantify the extent and development of the adaptive mutations that can lead to enhanced IAV infections and explore how these mutations contribute to viral genetic diversity produced from different primary cell types.